Calcineurin/NFAT signaling in pathogenesis of neurodegeneration in Down Syndrome

DESCRIPTION (provided by applicant): The development of individuals with trisomy 21/ Down Syndrome (DS) is characterized by delayed cognitive development in infancy and childhood leading to mild to moderate mental retardation, followed by a deterioration of cognitive abilities in adulthood due to the early onset of Alzheimer disease (AD). In fact, the deposition of amyloid protein (Aβ aggregates) is first observed in the second decade of life, and the full pathology of AD seems to be invariably present from 35 years of age onwards - fifty years earlier than in the normal population. The investigation of molecular processes that contribute to or modify the pathogenesis of AD in DS patients is important for the identification of new points of therapeutic intervention. While genetic studies have clearly confirmed the importance of triplication of the amyloid precursor protein (APP) gene, which is found on chromosome 21 (HSA21), in the pathogenesis of early onset AD in DS patients, the contribution of other HSA21 genes is still largely undefined. We have previously shown that increased dosage of two genes, DSCR1 (RCAN1) and Dyrk1a that are found on HSA21, cooperatively reduces the activity of the calcineurin/NFAT-signaling pathway during embryonic development. These studies suggest that perturbation of the calcineurin/NFAT genetic circuit contributes to many of the developmental phenotypes observed in DS. Calcineurin, RCAN1 and Dyrk1a have all also been implicated in AD pathogenesis. However, the results regarding their molecular and cellular role in AD (AD associated with DS or sporadic AD) has neither been systematically studied in genetic loss- of-function (LOF) or gain-of-function (GOF) mouse models nor in trisomy 21 patient cells and CNS tissues. In our studies we plan to answer the question whether overexpression of RCAN1 and Dyrk1a and the consequent decrease of calcineurin/NFAT activity, can synergize with increased APP gene dosage and expression to enhance Aβ deposition and neurofibrillary tangle formation in the CNS of DS patients. We will use mouse models to investigate whether changes in CaN activity and/or CaN activated NFATc-dependent transcription can alter the phosphorylation of tau and APP, the processing of APP or the response of hippocampal neurons to aggregated Aβ. We will evaluate the role of transcriptional targets of CaN/NFAT signaling in AD pathogenesis. Lastly we plan to examine the activation state and consequences of modulation of Dyrk1a, RCAM1 and CaN/NFAT signaling in CNS tissues and in induced pluripotent stem cell (iPSC) -derived neurons from human DS patients. At the conclusion of our studies we expect to have either provided evidence for or to have rejected the hypothesis that a 1.5-fold increase in the expression of Dryk1a and DSCR1 synergizes with increased gene dosage of APP in the early development of AD in DS patients. In addition, our studies will define the role of synergy between Dryk1a, DSCR1 and APP and possibly elucidate new roles for calcineurin-NFAT signaling that might be points of therapeutic intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: Down Syndrome (DS) is a common genetic disorder caused by an additional copy of all or part chromosome 21. Most individuals with DS show early-onset of Alzheimer's disease (AD). Located on chromosome 21 is the gene that encodes beta-amyloid precursor protein (APP), a key protein involved in the pathogenesis of AD. However, the extra copy of APP does not sufficiently account the early neurodegeneration in DS patients and additional genes on the chromosome 21 might be necessary for early AD onset in DS. We will test whether two additional genes synergize with APP. If this hypothesis is correct it might enable us to develop new treatments for some aspects of the disabling midlife deterioration of cognitive abilities in DS patients. Down Syndrome (DS) is a common genetic disorder caused by an additional copy of all or part chromosome 21. Most individuals with DS show early-onset of Alzheimer's disease (AD). Located on chromosome 21 is the gene that encodes beta-amyloid precursor protein (APP), a key protein involved in the pathogenesis of AD. However, the extra copy of APP does not sufficiently account the early neurodegeneration in DS patients and additional genes on the chromosome 21 might be necessary for early AD onset in DS. We will test whether two additional genes synergize with APP. If this hypothesis is correct it might enable us to develop new treatments for some aspects of the disabling midlife deterioration of cognitive abilities in DS patients. __SpecificAimsTextDelimiter__ Specific Aim 1: Determine if a reduction in calcineurin and/or NFATc activity can synergize with human APP in the development of AD-pathology. Down Syndrome (DS) patients have a greatly increased risk of early-onset Alzheimer's disease (AD). One of the genes known to contribute to the development of AD, amyloid precursor protein (APP), is encoded on HSA21. Trisomy of APP is likely to make a significant contribution to the early onset of AD in people with DS. However HSA21 genes other than APP may also contribute to the early onset of AD in people with DS. The HSA21 genes, RCAN1 and DYRK1a, synergize to inhibit calcineurin (CaN)/NFAT signaling and both have been implicated in the pathogenesis of DS and AD. Using forebrain-restricted, conditional loss- of-function mutants of CnB and NFATc1-c4 that have been crossed to APPswe/PS1ΔE9 transgenic mice, we will determine if genetic deletion of CaN and/or NFAT activity can affect the development of AD-like pathology in vivo. Specific Aim 2: Define the mechanistic basis of a genetic interaction between APP and RCAN1, Dyrk1a and Calcineurin/NFAT. If our experiments in Specific Aim 1 show that deletion of CnB and/or NFATc1-c4 affect the development of AD-like pathology in vivo, we will focus on changes in gene transcription in the transgenic animals. In this case we will also test whether forebrain- restricted expression of constitutively active NFATc4 can suppress any aspects of the AD-like phenotype seen in the APPswe/PS1ΔE9 transgenic mice. If however we find that only the deletion of CnB and/or the transgenic expression of RCAN1 and DYRK1a accelerate AD-pathology, we will focus our attention on posttranslational mechanisms such as hyperphosphorylation of Tau and APP and APP processing. We will examine if forebrain-restricted expression of active calcineurin can delay or prevent the AD-like phenotype in the APPswe/PS1ΔE9 transgenic mice. Our experiments will then also address the question whether inhibition of calcineurin activity can synergize with overexpression of DYRK1a and whether forebrain-restricted deletion of Dyrk1a can suppress any of the AD- phenotype in the APPswe/PS1ΔE9 transgenic mice. The elucidation of the exact nature of a synergistic interaction between APP and other HSA21 genes is critical to determine whether the modulation of CaN, NFAT or DYRK1a activity would be most promising as a therapeutic approach to delay the early-onset AD in DS patients. We will pay particular attention to DYRK1a, since it is an excellent therapeutic (druggable) target. Specific Aim 3: Examine whether postmortem CNS samples from DS patients show changes of calcineurin-NFAT activity. Our previous experiments indicate that embryonic DS tissues that overexpress DYRK1a and RCAN1 show hyper-phosphorylation of NFATc proteins, as predicted from a model in which synergy between DSCR1 and DYRK1a leads to reduced activation of the CaN/NFAT signaling pathway. We will therefore examine postmortem cortical and hippocampal samples of DS and AD patients for biochemical evidence and changes in gene expression that indicate an increase of DYRK1a/RCAN1 activity resulting in attenuation of calcineurin/NFAT signaling. Specific Aim 4: Differentiate induced pluripotent stem cell (iPSC) lines from DS fibroblasts into neural progenitors and mature neurons. We will determine whether neural progenitors and neurons that are differentiated from trisomic iPSCs show changes in gene expression and protein phosphorylation that are consistent with overexpression of RCAN1 and DYRK1a and a reduction of CaN/NFAT signaling. We will also functionally characterize the neuronally differentiated iPSCs and examine whether axonal transport defects attributed to increased APP expression, which have been observed in neurons cultured from DS mouse models, can be replicated in these trisomic human neurons. In addition, we will examine whether the phosphorylation state of Tau or APP and the processing of APP are altered.